Center Administrative Core

Administrative Core
ABSTRACT
The Administrative Core supports the goals of the Collaborative Center to Develop Improved Diagnostic and
Therapeutic Approaches to Endometriosis of developing advanced tools and insights for
improved understanding of the pathophysiology of endometriosis.
The overall objective of the Administrative Core is to ensure the effective and efficient operation of the Center.
The Administrative Core will achieve this objective by Promoting Communication (Aim 1). Multidirectional
communication will be enhanced by scheduled weekly, monthly, and yearly meetings that will have a clear pre-
set agenda. The Administrative Core will also Ensure Regulatory Compliance, Budgetary Compliance, and
Scientific Quality (Aim 2). Our emphasis will be on providing budgetary oversight and ensuring scientific rigor
and reproducibility, with assistance from the Research Integrity Officer (RIO) at UNC if needed. The
Administrative Core will also Oversee the Organization and Function of the External Advisory Committee (Aim
3). A board of 2 expert clinician-scientists and a basic scientist will serve to broadly discuss and critique the
program’s research efforts. Finally, the Administrative Core will Fund and Oversee the Pilot Project (Aim 4). The
pilot is intended to both extend the overall goals of the Center and support a project that will have a high likelihood
of future independent, external funding. Collectively, our four aims will provide guidelines whereby the
Administrative Core can facilitate data-sharing and interaction among the three large projects of the Center led
by four outstanding investigators, a pilot project, and two cores, further enhancing the synergism among the
research projects.
The Administrative Core, under the leadership of Dr. Young, will be assisted by a talented and experienced
administrator and research grant accountant. The infrastructure and support provided by the UNC Center for
Women’s Health Research, the Department of Obstetrics and Gynecology, and the UNC School of Medicine will
serve as a buttress to ensure the administrative success of the core. The multidirectional communication and
administrative leadership provided by this core will coordinate the research response with an ultimate outcome
of improving female reproductive health through successful prevention and treatment of endometriosis.